Post-transcriptional regulation of virulence in Campylobacter jejuni

ABSTRACT Campylobacter jejuni is a leading bacterial cause of gastroenteritis in the United States, and is responsible for sporadic disease as well as food-borne and water-borne outbreaks. It is also a Category B Bioterrorism Agent. There are at least 2 million cases of C. jejuni gastroenteritis each year in the U.S.;an incidence equal or greater to that of Salmonella and Shigella combined. A subset of C. jejuni infections lead to the development of Guillain-Barr[unreadable] Syndrome, an acute motor paralysis apparently resulting from an autoimmune response directed at C. jejuni surface antigens mimicking gangliosides. Despite the high prevalence of Campylobacter disease and more than 20 years of study, the mechanisms by which C. jejuni causes disease remain obscure. Several C. jejuni virulence factors have been identified, yet the mechanisms by which they are regulated remain largely unknown. Recently we have begun characterization of the C. jejuni ortholog of the post-transcriptional regulator CsrA. In other bacteria, CsrA mediates the regulation of numerous important virulence phenotypes, including carbon metabolism, motility, quorum sensing, biofilm production and others. CsrA activity is controlled by inducible small regulatory RNAs (sRNAs) that bind competitively to CsrA. We have constructed a C. jejuni mutant lacking csrA, and have shown that the csrA mutant exhibits pleiotropic virulence-related phenotypes including decreased motility, epithelial cell adherence, biofilm formation, and resistance to oxidative stress (including ambient air, hydrogen peroxide, and superoxide). Conversely, the csrA mutant shows increased invasion of human epithelial cells. This underscores the importance of the CsrA regulon in C. jejuni pathogenesis. Overall hypothesis: Campylobacter jejuni CsrA plays an important role in the pathogenesis of C. jejuni via the post-transcriptional regulation of virulence properties. We propose a detailed study of CsrA-mediated post-transcriptional gene regulation in C. jejuni, focusing on the mechanism by which CsrA controls the expression of virulence properties. We will use genetic, proteomic and biochemical approaches to achieve the goals outlined in these three specific aims: Aim 1) Continue characterizing the CsrA regulon and cis-acting factors required for CsrA regulation of these proteins, Aim 2) Identify and characterize the sRNA component that antagonizes CsrA activity, and Aim 3) Identify environmental conditions and regulatory proteins that control expression of csrA.

Public health relevance
NARRATIVE Campylobacter jejuni is one of the leading bacterial causes of gastroenteritis in the United States, infecting approximately two million persons annually, and a subset of Campylobacter-infected persons subsequently develop the acute paralytic disease Guillain-Barré Syndrome (GBS). The pathogenesis of Campylobacter infections is severely understudied relative to other enteric infections such as those caused by Salmonella and E. coli, and precisely how Campylobacter causes disease is largely unknown. Campylobacter has a relatively small repertoire of gene regulation systems, and it is unclear how it is able to fine tune gene expression to result in a productive infection of humans. This work outlines the characterization of a novel, posttranscriptional form of virulence gene regulation that we recently were the first to begin characterizing in Campylobacter.